CANANOLAB NANOMATERIALS DATABASE EXPANSION

Expand usability of caNanoLab database: caNanoLab is a cancer nanomedicine data repository supporting nanotechnology programs within NCI. The expanded support facilitated by this request will enable database expansion and increase data access and usability to the research community.